Understanding immigrants' cardiovascular disease utilization: An epidemiological and system dynamics approach

PROJECT SUMMARY
Cardiovascular disease (CVD) is one of the leading causes of mortality for most racial and ethnic groups in the
U.S. When immigrants first arrive in the U.S., they have better CVD risk factor profiles than the U.S.-born, but
within 5 to 15 years of living in the U.S., they experience a worsening of their CVD risk factor profiles.
Immigrants of color, specifically some Black, Latinx and Afro-Latinx immigrants, have lower screening,
monitoring, and treatment of CVD risk factors than U.S.-born populations. Lower preventive care utilization
likely contributes to their worsening cardiovascular health. Eliminating disparities in CVD preventive care
utilization is necessary to improve the cardiovascular health trajectory of immigrants of color and lessen the
burden of CVD mortality in the U.S. The research objective of this career development award is to use
epidemiologic, system dynamics, and community-engaged methods to understand how individual and multiple
components of the sociopolitical environment affect Black and Latinx immigrants’ CVD preventive care
utilization. This research will also address current gaps in immigrant health research by focusing on CVD
preventive care utilization outcomes, including Black immigrants in the study population, and using objectively
measured, longitudinal electronic health record data (EHR). The research objective will be achieved through
three novel aims. Aim 1 is to estimate trends and associations between state and county-level immigration
enforcement rates (e.g., community arrests), hate crimes rates, and CVD preventive care utilization among
Black and Latinx immigrant adults using electronic health record data from a nationwide network of community
health centers. Aim 2 is to develop a system map with community stakeholders that graphically depicts
hypothesized causal relationships and feedback loops within the sociopolitical environment that affect
immigrants’ CVD preventive care utilization. Aim 3 is to develop a system dynamics simulation model to
estimate improvements in CVD preventive care utilization as different components of the immigrant-related
sociopolitical environment are manipulated. This multidisciplinary research plan directly addresses NHLBI’s
critical challenge to advance methods of assessing and characterizing exposures to understand differences in
health among populations. The research aims are complemented with a training plan that builds upon the
candidate’s expertise as social epidemiologist to develop the candidate’s expertise in the (1) measurement and
quantification of non-policy components of the sociopolitical environment, (2) analysis of longitudinal EHR data,
(3) use of system dynamics simulation methods, and (4) use of community-engaged research and community-
based system dynamics methods. Together, the research and training plans will prepare the candidate to
become an interdisciplinary, independent research investigator whose career is aimed at improving the
cardiovascular health trajectories of immigrants of color in the U.S.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is one of the leading causes of mortality in the U.S. and lowering the burden of CVD through prevention and treatment is important to public health. Immigrants of color have lower awareness, screening, monitoring, and treatment of CVD risk factors than U.S.-born populations, which may contribute to the observed decline in their cardiovascular health over longer residence in the U.S. This project will use epidemiologic, system dynamics, and community-engaged methods to understand and quantify how different facets of the sociopolitical environment affect Black and Latinx immigrants’ CVD preventive care utilization.